Pre-clinical testing of a novel gene therapy for pediatric neurodegenerative disease

PROJECT SUMMARY
A significant number of pediatric neuromuscular and neurodegenerative conditions are caused by recessive
gene mutations resulting in loss of both maternal and paternal copies of a gene. These genes may encode for
proteins that play critical roles in cell differentiation, cell survival, and/or cell function(s). Current medical
management strategies attempt to delay disease progression or minimize symptoms of these conditions, yet
they do not address the underlying genetic deficiency. Gene replacement therapy is a treatment approach that
provides back to cells a functional copy of a gene, thereby overcoming the deficiency caused by genetic
mutations and permanently rescuing cell differentiation, survival, and/or function to a degree that the disease is
halted or prevented entirely. This approach utilizes an AAV9 virus to deliver functional copies of a gene to cells
of interest based, in part, on how the therapy is administered. Gene therapies have potential to revolutionize
treatment of pediatric diseases, as was demonstrated recently by the FDA approval of a gene therapy for spinal
muscular atrophy. As part of this study, we are testing a novel gene therapy for childhood-onset striatonigral
degeneration, a severe progressive neurologic disease caused by recessive mutations in the VAC14 gene.
Patients with this condition develop signs of neurodegeneration in the first half-decade of life that progresses
rapidly and results in severe neurologic and neuromuscular deficit that is not responsive to current medical
treatments. To study this further, we engineered the first viable pre-clinical mouse model of this condition (termed
Vac14ducky). Vac14ducky mice develop neurologic disease associated with accumulation of vacuoles within the
brain cortex, spinal cord, and dorsal root ganglia. The vacuolization observed in Vac14ducky mice is similar to
vacuole formation previously demonstrated in patient-derived fibroblasts. We developed a novel gene therapy
product (AAV9-hVAC14opt) expressing the human VAC14 gene transcript, and using our novel Vac14ducky mice,
we performed preliminary in vivo efficacy and toxicology evaluations. Following a single intrathecal injection at 7
days of age, our results thus far demonstrate that AAV9-hVAC14opt successfully rescues overall health and
motor function in adult Vac14ducky mice. Additionally when treating control mice, AAV9-hVAC14opt showed no
detectable toxicities. These preliminary results suggest AAV9-hVAC14opt is a potential novel gene therapy for
the pediatric VAC14-associated neurodegenerative disease. The study proposed here will test a dose-response
that is required for an IND application. Aim 1 determines the minimal effective dose of AAV9-hVAC14opt needed
to provide therapeutic benefit in Vac14ducky mice as well as in the more severe mouse line Vac14ingls. Aim 2 tests
the post-symptomatic treatment efficacy utilizing Vac14ducky mice as well as Vac14ingls mice. The complementary
Aims of this proposal will provide critical evidence demonstrating AAV9-hVAC14opt as a novel gene therapy for
this severe pediatric condition. At the completion of this study, we will be prepared to proceed toward an IND
application for eventual testing in patients.

Public health relevance
PROJECT NARRATIVE We engineered the first viable pre-clinical mouse model (termed Vac14ducky) of the pediatric VAC14-associated neurodegenerative disease, and using this new model, we have developed and completed preliminary analyses of a novel gene therapy (AAV9-hVAC14opt) for this disease. Following a single neonatal intrathecal injection of AAV9-hVAC14opt, the overall health and motor function of adult Vac14ducky mice was successfully rescued compared to vehicle-treated mice, with no detectable toxicities in control mice. Building on these exciting and promising results, the study proposed here will 1) define a minimal effective dose and 2) test post-symptomatic efficacy of AAV9-hVAC14opt in anticipation for IND application to the FDA.